Mechanisms of Vaccine Immunity against Coccidioidomycosis

ABSTRACT
We will exploit a live attenuated ∆cps1 (null) strain of Coccidiodes posadasii to vaccinate against coccidiodomycosis, and
elucidate the mechanics by which the lung epithelium coordinates the induction of durable T cell immunity against infection.
Host resistance against inhaled pathogens is thought to reside with lung tissue-resident memory (TRM) cells and mucosal
immunity, but little is known about whether or how a fungal vaccine creates resident T cell immunity at the lung mucosa.
Our preliminary data reveal that mucosal vaccination elicits protective, Coccidioides endoglucanase 2 (C-Eng2) specific
CD4+ T cells and that the lung epithelium is required to mobilize myeloid and lymphoid cells in response to the vaccine.
This network of stromal and hematopoetic cell responses to vaccination has not been studied and is the subject of this project.
To define cellular and molecular mechanisms required to elicit protective immunity at the lung mucosa, we have created
innovative tools: i) a novel protective antigen C-Eng2 and peptide:MHCII tetramers to track and enumerate protective CD4+
T cells in C57BL6 in mice; ii) transgenic mice in which epithelial cells and their products are able to be conditionally deleted
to dissect their role in generation of immunity; and (iii) a novel system of isolating and culturing human lung epithelium to
translate results from mice to humans. We hypothesize that the mucosal delivery of ∆cps1 vaccine spores promotes devel-
opment of protective TRM cells and that the lung epithelium coordinates durable protective immunity. We aim to:
1. Probe the intial stages of vaccine recognition and response by innate immune cells in lung. We will test the hypothesis
that lung epithelium and their products regulate mobilization of innate immune cells that recognize and restrain growth
of ∆cps1 vaccine spores, and also captures them to present their peptides to naïve T cells in the draining lymph nodes.
2. Elucidate intracellular signaling pathway during lung epithelial cell regulation of innate response to ∆cps1 vaccine.
We will test the hypothesis that Ca++ and calcineurin dependent signaling events within the lung epithelium contribute
to the dectin-1 dependency of host inflammatory responses to Coccidiodes spp. and vaccine in both mice and humans.
3. Define mechanisms of durable T cell immunity elicited by vaccination at the lung mucosa. We will test the hypothesis
that lung epithelium shapes the phenotypic, functional and transcriptomic features of protective C-Eng2-specific CD4+
T cells following intransal administration ∆cps1 vaccine spores .
Our work will exploit a highly effective vaccine against coccidioidomycosis to elucidate the mechanisms of lung immunity
following mucosal administration. Little is known about the mechanisms of vaccine-induced protective immunity at the
lung mucosa, and how the lung epithelium regulates the early recognition and restraint of vaccine spores and generation of
protective T cells. Vaccination against coccidioidomycosis, an important public health problem, is a major unmet medical
need. We anticipate that new insight into the mechanistic underpinnings of vaccine induced mucosal resistance, and the
immune correlates of vaccine resistance will advance the development of preventive measures against coccidioidomycosis.

Public health relevance
NARRATIVE This proposal will investigate the mechanisms that underpin effective vaccination against the systemic fungal infection Coccidioidomycosis. A live attenuated vaccine strain of the fungus has been developed and is known to protect against lethal infection, following vaccine delivery intranasally. It is widely believed that local immunity is mobilized by the vaccine and this proposal will clarify the necessary elements required for establishing this vaccine immunity.